Core 2: Histopathology and Biospecimen Core

Project Summary/Abstract – Histopathology and Biospecimen Core
The Histopathology and Biospecimen Core (HBC) represents an integral component of the Fred Hutchinson
Cancer Research Center (FHCRC) lung cancer SPORE, supporting the translational goals of the Projects as
well as future SPORE-funded development projects. The mission of the HBC is to facilitate discovery and rapid
translation of discoveries into clinical care. To this end, the HBC manages the acquisition, annotation,
processing and distribution of biospecimens from patient-derived and SPORE-funded experimental mouse
models. The HBC partners with NWBioTrust (NWBT), and Fred Hutchinson/University of Washington Cancer
Consortium (CCSG) – a funded collaborative resource for obtaining high-quality, well-annotated and
appropriately-consented and de-identified biospecimens for innovative research. In addition to biobanking
activities, the HBC is responsible the for managing the performance of downstream tissue-based assays,
leveraging a suite of cutting-edge histopathologic and imaging capabilities supported by the Fred Hutchinson
Cancer Research Center (FHCRC) in its extensive network of Shared Resources. These capabilities include,
but are not limited to, routine histopathologic services, pathology review and consultation, immunohistochemistry
(IHC), branch-chain in-situ hybridization (ISH), DNA/RNA extraction, Nanostring-based transcriptional profiling,
multiplex immunohistochemistry (mIHC) and digital image analysis. The HBC will provide SPORE investigators
with biospecimens (e.g. serum), derivatives of biospecimens (e.g. unstained slides, DNA,RNA) as well as qualitycontrolled data (e.g. images and image analysis-based data).

Public health relevance
Project Narrative – Histopathology and Biospecimen Core The Histopathology and Biospecimen Core (HBC) will manage the acquisition, annotation, processing, and distribution of biospecimens to SPORE investigators. In addition, the HBC provides state-of-the-art tissue-based analysis capabilities, including but are not limited to, routine histopathologic services, pathology review and consultation, immunohistochemistry (IHC), branch-chain in-situ hybridization (ISH), DNA/RNA extraction, Nanostring-based transcriptional profiling, multiplex immunohistochemistry (mIHC) and digital image analysis.